STUDIES ON THE MYOCARDIAL EFFECTS OF HETEROCYCLIC AMINES

The question of whether heterocyclic amines (HAs) in cooked meats could be associated with idiopathic cardiomyopathies was raised by studies showing that cynomolgus monkeys chronically treated with 2-amino-3- methylimidazo[4,5-f]quinoline (IQ) for carcinogenicity testing had elevated levels of DNA adducts in the heart and developed foci of cardiac myocyte necrosis. We developed models to investigate mechanisms of HA- induced cardiotoxicity. Primary cultures of fetal myocytes were exposed to IQ, PhIP, or the activated forms of these carcinogens N-hydroxy-IQ and N-hydroxy-PhIP. LDH leakage increased in proportion to the dose of the N-hydroxylamine; however, little toxicity was seen with the parent amines. Electron microscopy revealed that cells treated with the N-hydroxylamines had swollen and irregular mitochondria and fewer organelles. DNA adducts, measured by the 32-P-postlabeling method, appeared to correlate with the degree of toxicity with each compound. The toxic effects of heterocyclic amines were also evaluated in rats given IQ or PhIP (100 mg/kg, p.o. 10x). Light microscopic and ultrastructural cardiac abnormalities were present in seven of eight rats exposed to IQ or PhIP. Whereas control animals had a normal cardiac morphology, carcinogen-treated animals had foci of chronic inflammation with myocyte necrosis, myofibrillar dissolution and disarray, and dilation of T-tubules. These results suggest that, in addition to being carcinogenic, the food mutagens may play a role in cardiac degeneration. The results from in vitro studies implicate the N-hydroxylamines in the cardiotoxicity of the HA-food mutagens. Studies on the possible protective effects of N-acetylcysteine and alpha-tocopherol are underway. The possible contribution of HA-induced oxidative damage in the myocardium is being pursued.